Administrative Core

ABSTRACT: ADMINISTRATIVE CORE
We seek support to expand our NW NARCH program, building upon successful experience with our earlier
rounds of NARCH funding for various research and trainee development projects. We bring many years of
collaborative experiences to the NARCH—including collaborations among Northwest Portland Area Indian
Health Board, OHSU, and Portland State University. Our Administrative core will help facilitate activities
among the three partners, and is organized to support the overall success of the Northwest NARCH.
Our Administrative Core’s specific aims include the following:
1. To provide administrative leadership and oversight for the component NARCH 12 projects
described in this application and align these activities with existing NARCH training and
research projects;
2. To provide process and outcome evaluations for component projects within our NARCH 12 application;
3. To report NARCH progress to the delegates from the 43 NW tribes, to national NARCH project officers,
to upper level administrators (deans and provosts) at the partner universities, and to Community and
Scientific Advisors;
4. To seek out and disseminate information to collaborators on research and training opportunities for
investigators, mentors, and students; and
5. To support investigators’ travel to the annual NARCH director meetings and scientific meetings.
Our Administrative Core is designed to efficiently and effectively serve needs of the component NARCH
projects that are described in this application. The PI and NARCH program investigators will be guided by the
Community and Scientific Advisory Board, who are well known to the Indian Health Board and to the NARCH
program. Members of this panel served the NARCH in earlier rounds, and are either American Indian
community health experts, scientific experts related to Indian health—or both. They have provided their input
for this application, and are as excited as we are to see us implement our projects. Our projects are in direct
alignment with NARCH program goals, and with the NIH Strategic Plan for Tribal Health Research FY 2019-
2023. We trust that our efforts will serve the tribes in our region, and beyond.